Toward Clinical Trial: AXL-STAT3 Targeting of Lung Tumor Microenvironments

ABSTRACT
Dynamic lung tumor microenvironments (TMEs) contain a myriad of cell subtypes, each providing a unique
functionality in support of malignant growth. To prepare a metastatic niche, a tight signaling network must be
present to coordinate the delivery and sharing of co-stimulatory signals among malignant and non-malignant cell
populations. AXL and STAT3 cascades are critical components of intra- and intercellular signaling networks, as
they translate multiple external stimuli into specific cellular responses. Single cell profiling of lung tumors reveals
that AXL collaborates with STAT3 to generate a unified tumor ecosystem that promotes hybrid epithelial-to-
mesenchymal transition (EMT), pro-tumorigenic remodeling of fibroblasts and M2 polarization of macrophages.
Disruption of AXL-STAT3 network not only compromises this co-dependency in lung cancer cells implanted in
xenograft mice, but also limits the tumor cells' ability to conscript supportive host cells to form a symbiotic
community. We hypothesize that combined targeting of AXL-STAT3 network disrupts the communication
among diverse cell subtypes, thereby inhibiting lung tumor growth and metastatic spread. In Aim 1a, we will
conduct knockdown and knockout experiments in lung cancer, fibroblast and monocytic cell lines to explore the
relationship between AXL-STAT3 pathway and macrophage differentiation in co-culture systems. We will
demonstrate that AXL-STAT3 network in lung cancer cells and fibroblasts exerts a paracrine effect via IL-11
secretion on macrophages to sustain STAT3 signaling for M2 polarization and stemness mimicry. In Aim 1b, in
vivo drug testing of AXL and JAK inhibitors in CD34+ humanized NSGTM-SGM3 mouse xenograft models will
evaluate AXL-STAT3 drug targeting effects on host cell recruitment, hybrid EMT phenotypes, macrophage
plasticity and pro-tumorigenic remodeling of stromal fibroblasts. In Aim 2, we propose a phase Ib/II study to
determine safety and efficacy of dubermatinib (AXL inhibitor) and momelotinib (JAK inhibitor) in patients with
metastatic lung adenocarcinoma. In Aim 2a, a Bayesian Optimal Interval design will identify the MTD of
momelotinib in combination with dubermatinib with a target toxicity rate 30% in 18 patients. In Aim 2b, we will
conduct a prospective phase II, single-arm comparison of progression free survival in 26 patients treated with
combination dubermatinib and momelotinib versus an historical control. Correlative studies include pre- and post-
treatment paired lung tumor and liquid biopsies to determine if combined treatment can disrupt AXL-STAT3
signaling network in malignant and non-malignant cell populations and reprogram aggressive tumor
microenvironments. AXL-STAT3 targeting to restrain TMEs is a promising therapeutic strategy in patients with
advanced lung adenocarcinoma. This R01 proposal will address an important question regarding the efficacy of
combination treatment with AXL inhibitor and JAK inhibitor (for STAT3 signaling blockade) in lung cancer patients
and will provide a treatment stratification model based on intercellular crosstalk between AXL-STAT3 signaling
for an extended clinical trial.

Public health relevance
PROJECT NARRATIVE AXL and STAT3 signaling coordinate and exert a paracrine effect on malignant and non-malignant cells in the lung tumor microenvironment, nurturing a metastatic niche. The proposal will address an important question regarding combination of AXL inhibitors and JAK inhibitors (for STAT3 signaling blockade) as a promising targeting strategy in lung cancer patients and will provide a treatment stratification model based on intercellular crosstalk between AXL and STAT3 signaling to a potential extended clinical trial.